Reprogramming of the stromal microenvironment in melanoma progression and therapeutic escape

Although the approval of novel targeted therapy drugs, such as BRAF inhibitors (BRAFi), MEK inhibitors (MEKi),
and immune checkpoint inhibitors, has revolutionized melanoma treatment, long-term outcomes are still
disappointing for many patients because of the development of drug resistance. A major contributing factor to
tumor resilience and relapse is the presence of a “plastic” microenvironment, which is comprised of
heterogeneous stromal cell populations embedded in a dense and stiff extracellular matrix (ECM). Particularly,
the ECM not only functions as a barrier to drug penetration and distribution and also provides structural and
adaptive signals, which can induce therapeutic escape pathways in melanoma cells. Genetically stable cancer-
associated fibroblasts (CAFs) are known to be a notorious ECM-remodeling machine in the tumor stroma. We
have discovered that the number of CAFs with nuclear β-catenin in the melanoma stroma increases significantly
after the patients are treated with BRAFi/MEKi. We have established that increased nuclear β-catenin in CAFs
is induced by BRAFi but not MEKi. Nevertheless, how BRAFi stimulates CAFs to reprogram their biological
functions via hyperactivated nuclear β-catenin activity remains to be understood. We have obtained compelling
data demonstrating that targeted depletion of β-catenin in CAFs ablates their ability to remodel the tumor
microenvironment, downregulates abnormal BRAF/MAPK/ERK signaling in melanoma cells, and suppresses
melanoma cell drug resistance in vitro and in vivo. RNA-Seq data show that β-catenin is essential for CAF to
remodel the ECM by coining the CAF transcriptome. We have identified the β-catenin/TCF4 target gene periostin
(POSTN) as an important matricellular protein secreted by CAFs to promote BRAFi resistance. The central
hypothesis is that decoding and targeting the ECM-remodeling CAFs has the potential to create a drug-sensitive
microenvironment that sensitizes melanoma cells to therapeutic agents and increase their response rate. In Aim
1, we will elucidate the pro-activation pathway(s) by which BRAFi stimulates CAFs to mediate melanoma drug
resistance phenotypes. We will assess the role of hyperactivated nuclear β-catenin in the function of CAFs in
melanoma. In Aim 2, we will determine whether the β-catenin-TCF4 transcriptional complex is the signaling hub
that controls CAF-driven ECM remodeling and BRAFi/MEKi resistance. We will evaluate whether disrupting the
β-catenin-TCF4 interaction in CAFs will sensitize BRAF-mutant melanoma cells to BRAFi/MEKi in vivo. In Aim
3, we will determine the roles of CAF-derived POSTN in melanoma cell growth and resistance to BRAFi/MEKi.
We will investigate signaling pathways that are activated by POSTN in melanoma cells to promote their
proliferation and resistance to BRAFi. The expected outcomes are to be an in-depth mechanistic characterization
of the complex interactions among CAFs, BRAFi, and the ECM microenvironment that promote the growth and
drug resistance in BRAF-mutant melanoma cells. The knowledge obtained will open the possibility of developing
a “magic bullet” that could destroy the tumor niche to improve targeted therapy and optimize patient outcomes.

Public health relevance
The current challenges in melanoma targeted therapy are due to an incomplete understanding of the mechanisms underlying the key influence of the tumor microenvironment on tumor cell response to therapeutic agents. The goal of the proposed project is to systemically explore how cancer-associated fibroblasts (CAFs) respond to BRAF inhibitors and remodel a protective tumor niche that induces growth and therapeutic escape in melanoma cells. The knowledge gained will advance the understanding of the contribution of CAFs in treatment responsiveness and melanoma recurrence. If successful, the data will accelerate the development of novel strategies to co-target both melanoma cells and the host microenvironment for improved patient outcomes.